Treatment of Alzheimer's disease by clearing both tau and amyloid beta pathologies

PROJECT SUMMARY
Alzheimer’s disease (AD) is the sixth leading cause of death in the United States. Nearly six million Americans
suffer from AD, at an annual cost of almost $300 billion for their health care. At present, no effective treatment
of this disease is available. If no treatment is found that can inhibit, prevent, or cure this disease, the number of
cases will triple by 2050. Thus, there is an urgent need to develop an effective treatment for AD. AD is
histopathologically characterized by the occurrence of numerous Aβ plaques and neurofibrillary tangles of
abnormally hyperphosphorylated tau in the brain. Tau pathology of hyperphosphorylated tau is also a hallmark
lesion of several related neurodegenerative diseases, called tauopathies. The density of tau pathology, and not
of Aβ plaques, correlates with the degree of dementia in AD patients. There is increasing belief in the field that
the clearance of both Aβ or tau pathologies could be required to successfully treat AD. So far, none of the
antibodies used in human clinical trials have had such activity. We have generated several high-affinity tau
mouse monoclonal antibodies, and one of these, tau antibody 43D to human tau 6-18, can clear not only tau
pathology but also Aβ pathology and rescued cognitive impairment in the 3xTg-AD transgenic mouse model of
AD and tauopathy. We propose to further develop this unique tau antibody for immunotherapy of AD and related
conditions. The PI has patented 43D for the treatment of AD and related neurodegenerative disorders. The
specific aims of this SBIR Phase I application are (1) to study the humanization of the tau mouse monoclonal
antibodies 43D and 77E9 and (2) to study the immunotherapy activities of the humanized antibodies from Aim 1
in comparison with the corresponding mouse monoclonals in 3xTg-AD transgenic mice treated with AD ptau.
Hyperphosphorylated tau (ptau), free from any Aβ and TDP43, will be isolated from AD frozen autopsied AD
brain and used to induce tau seeding and spread in 3xTg-AD mice, which will be immunized with humanized
43D in comparison with a Aβ-negative effective tau antibody 77E9 to tau 184-195 and the corresponding mouse
monoclonals. The effect of immunization of tau and Aβ pathologies will be evaluated immunohistochemically and
biochemically. These Phase I studies will be followed by a Phase II application on generation of a cell line of the
lead humanized antibody with similar or higher activity as the corresponding mouse monoclonal and then leading
to large-scale GMP manufacture, IND, and test of cross-reactions and non-target tissue binding, along with the
safety studies and human clinical trials. The successful completion of the proposed studies will lead to Phase I
human clinical trials in healthy volunteers and Phase II and then Phase III human clinical trials on AD and related
neurodegenerative conditions and will potentially lead to the treatment and prevention of these diseases. At
Phanes Biotech, we believe that given its multifactorial nature and heterogeneity, AD could require a combination
therapy. While on one side we are developing the neurotrophic compound P021 to stimulate regeneration of the
brain, combining it with tau immunotherapy, which can inhibit neurodegeneration, could further increase our
success and is the long-term goal of our company.

Public health relevance
PROJECT NARRATIVE Almost six million people in the United States alone have Alzheimer’s disease (AD), and as yet, no effective drug that can prevent, inhibit, or reverse this disease is available. The specific objective of the proposed SBIR Phase I research project is to study the humanization and the biological activities of mouse monoclonal antibodies to the amino-terminal domain of tau that can clear both tau and Aβ pathologies, which are associated with AD, in a mouse model of AD and tauopathies. These studies will lead in our eventual Phase II application to IND regulatory studies and then human clinical trials for the treatment of AD and related disorders.